Identifying Risk Factors for Antibiotic Resistance via Integration of Epidemiology and Metagenomics

PROJECT SUMMARY
Given the growing burden of antimicrobial resistance (AR) and lack of effective therapies for multi-drug
resistant organisms, the development of new tools or models which risk-stratify patients for colonization and
infection by AR bacteria is of paramount importance, particularly in high-risk populations. The significance of
the gut microbiome in mediating colonization resistance against drug resistant pathogens as well as the role of
microbiota-depleting antibiotics in the development of AR infections is being increasingly appreciated.
However, there is currently a deficiency of methods integrating microbiome and antibiotic factors into AR-
predictive algorithms. Thus, the overall objective of the proposed research is to improve understanding of the
factors driving the epidemiology of AR-colonization and infection by incorporating metagenomic and antibiotic
administration data of a well-defined clinical cohort. In this proposal, we focus on patients with acute
myelogenous leukemia (from whom we have already collected extensive longitudinal stool samples and
performed 16S rRNA gene sequencing) because of the high rates of AR pathogen colonization and severe risk
for infection. The overarching hypothesis that will be tested is that the baseline presence of a limited number
of key bacterial species and antibiotic resistance genes (ARGs) are critical for the risk of colonization and/or
infection with an AR pathogen when combined with the administration of specific antimicrobials. We will begin
our research by comprehensively determining the epidemiology of AR pathogen colonization and AR infection
in our cohort via culture based stool sample analyses and clinical chart review, respectively. Using shotgun
metagenomics, we will establish whether the baseline intestinal microbiome species and resistome
characteristics are associated with the acquisition of AR pathogens colonizing or causing infection. Similarly,
we will ascertain the relationship between antimicrobial exposure, microbiome disruption, and subsequent AR
emergence. The data from these studies will be integrated into Decision Tree (DT) and Random Forest (RF)
models to improve the prediction of AR pathogen colonization and AR infection outcomes. The proposed
career development award, which utilizes the expertise of a superlative mentorship team and a uniquely
designed research and training plan, will enable me the opportunity to build upon my current expertise in
microbiology, genomics, and molecular epidemiology by adding advanced training in shotgun metagenomic
analyses, bioinformatics, and biostatistical modeling. Moreover, the numerous resources and support provided
by my institution and mentoring team will ensure my successful transition to an independent investigator as
well as establish a strong foundation for my long-term goals of understanding and mitigating the impact of
antimicrobial resistance in human health via integration of multiple –omics platforms and provision of
personalized genomic-based medicine.

Public health relevance
PROJECT NARRATIVE Antibiotic resistant (AR) infections are one of the most serious public health threats and a leading cause of morbidity and mortality, particularly in immunocompromised patients. The proposed research will use a combination of culture-based techniques and high-throughput approaches to determine the epidemiology of colonization and infectious events by AR-pathogens, characterize the gut microbiome, and mine clinical data of acute leukemia patients receiving chemotherapy in order to identify microbial species, antibiotic resistance genes, patient features, and antibiotic administration factors that affect the risk for colonization and/or infection with an AR pathogen. The ultimate goal of the proposed research is to exploit metagenomics as an epidemiological tool for understanding susceptibility to AR outcomes and to build predictive risk models which can be potentially incorporated into prevention and intervention strategies to mitigate AR infection events in high-risk patients.